Investigating the Roles of Phospholipase A2s and Diacylglycerol Signaling in Ferroptosis

PROJECT SUMMARY
Despite rapid advances in cancer therapeutic development, acquired drug resistance continues to
threaten the long-term efficacy of existing chemotherapeutic agents, necessitating the expansion of treatment
options targeting novel mechanisms to induce tumor cell death. To that end, induction of ferroptosis, a non-
apoptotic, regulated cell death modality, has been shown to be a promising anti-cancer strategy. To date,
ferroptosis susceptibility has been demonstrated in many cancer cell types, including clear-cell renal carcinoma
and hepatocellular carcinoma25. Ferroptosis has also been shown to be involved in the therapeutic mechanism
of existing therapies including sorafenib, a multi-kinase inhibitor, and immune checkpoint blockade
therapy26,27,30. Furthermore, multiple studies have reported that therapy-resistant cancer cells that persist after
conventional first-line drug treatments or that have undergone epithelial-to-mesenchymal transition exhibit an
increased dependency on a druggable phospholipid hydroperoxidase enzyme, namely glutathione peroxidase
4 (GPX4)22-24, the central component and major inhibitor of the ferroptotic cell death pathway. Therefore,
defining the molecular mechanisms governing ferroptosis will likely reveal potential targets for the development
of novel cancer therapeutics.
Ferroptosis is characterized by extensive lipid peroxidative damage to biological membranes that
overwhelms the ability of GPX4 to detoxify these lipid reactive oxygen species, eventually leading to cell death.
While the central mechanisms of this regulated cell death pathway have been elucidated, the mediators of
ferroptosis susceptibility are not fully characterized and the molecular signals and events that ultimately result
in cellular demise remain unknown. Our lab and others have demonstrated that widespread changes in the
cellular lipidome occur during ferroptosis, characterized by the significant upregulation of lysophospholipids
and certain polyunsaturated fatty acid-containing diacylglycerols (PUFA-DAGs)2-7. The mechanisms that
mediate these changes and the functions they play in ferroptosis are as yet unknown. In this study, I will use
small molecule dose response, genetic modulation techniques, and lipidomic profiling to investigate the role of
phospholipase A2s (PLA2s, lipid remodeling enzymes that generate lysophospholipids), and PUFA-DAG
signaling pathways in ferroptosis. I propose that specific phospholipase A2 enzymes (specifically, ABHD12,
PLA2G15, and PLA2G10) are active in the removal of key sensitizing lipid species from the membrane and
potentially in the repair of oxidatively damaged membranes during ferroptosis (Aim 1). I further propose that
specific PUFA-DAGs coordinate downstream signaling cascades through activation of certain protein kinase C
subtypes, which have been implicated in oxidative stress pathways15, directing the cell toward cell death (Aim
2). A tipping of the balance between these opposing processes may determine cell fate.

Public health relevance
PROJECT NARRATIVE Ferroptosis is an iron-dependent, oxidative form of regulated cell death that is morphologically and biochemically distinct from other cell death pathways, and has been implicated in numerous cancer therapies and natural tumor suppression mechanisms. This proposal will utilize small molecule and lipid probes, genetic modulation techniques, lipidomic profiling and activation state assays to investigate the roles of lipid remodeling and lipid-responsive signaling pathways in mediating ferroptotic cell death. Building a more comprehensive model of the molecular networks involved in ferroptosis may uncover new avenues of research to exploit this cell death pathway for therapeutic benefit in cancer.